NHLBI Data Stage Coordinating Center

This application describes our proposed approach to the coordination of the National Heart, Lung, and Blood Institute (NHLBI) Data Storage, Toolspace, Access and analytics for biG data Empowerment (STAGE) program in support of the NHLBI vision to leverage the National Institutes of Health (NIH) Data Commons infrastructure in order to address the specific needs of NHLBI researchers. As the NHLBI STAGECC, we will manage and coordinate the diverse Data STAGE Consortium teams and stakeholders in order to collaboratively develop novel functionality that will fundamentally change the data and computational resources available to advance NHLBI research and support the NHLBI Strategic Vision. Specifically, we will work to effectively and efficiently build a data-science platform (Getoor et al., 2016) for high-value heart, lung, blood, and sleep (HLBS) datasets ( Exhibit 1 ). The STAGECC will work across the NHLBI Data STAGE Consortium to align a common view of the Data STAGE vision and transform that vision into a practical and relevant implementation that meets researcher needs. Our team is committed to an approach that fosters a community of practice, ensures clear and transparent communication, supports an inclusive and diverse environment, is conducive to listening and identifying synergies, disseminates ideas effectively, and provides balanced leadership. As a team, we will build from our experience orchestrating community-developed software applications and our many years of service as leaders and coordinators of large, multifaceted collaboratives. We will apply established strategies for community engagement, project management, communication, and reporting. As research on HLBS disorders evolves and the Data STAGE matures, our approach as the STAGECC will adapt and foster continuous community engagement aimed at creating and coordinating solutions in support of discovery.